RAMP-altered class B GPCR hormone binding and signaling

SUMMARY/ABSTRACT: Three receptor activity-modifying proteins (RAMP1-3) in humans form heterodimers
with the class B G protein-coupled receptors (GPCRs) calcitonin receptor (CTR) and calcitonin-like receptor
(CLR) and modulate their responses to six CGRP family peptide hormones. This complex system of seven
receptors and six ligands is a model for understanding class B GPCR signaling mechanisms and modulation of
GPCR function by accessory membrane proteins. CGRP family peptide signaling through CTR, CTR-
RAMP1/2/3, or CLR-RAMP1/2/3, is involved in diverse processes including calcium homeostasis, blood
glucose regulation, pain signaling, neuroimmune communication, and development and maintenance of the
cardiovascular and lymphatic systems. Consequently, the receptors are drug targets for osteoporosis,
diabetes, obesity, migraine headache, and cardiovascular and lymphatic disorders. We have used
biochemistry, pharmacology, and structural biology approaches to study how the peptides bind and activate
the receptors, how the RAMPs determine ligand selectivity, and how the peptide-bound receptors couple to G
protein transducer to promote cAMP signaling. Our studies advanced our understanding of each of these areas
and enabled us to engineer novel peptide antagonists and agonists with useful properties like increased
receptor affinity, altered receptor selectivity, or long-acting signaling. These have been powerful tools for
studying the receptors and may have promise as therapeutic leads. More recently, we discovered temporal
differences in the signaling properties of the CGRP family peptides that likely contribute to their diverse
biology. Some of the peptides promote cAMP signaling of short duration, whereas others elicit long duration
signaling. Despite these advances, several areas need more study. How RAMPs determine ligand selectivity is
only partially understood. Our understanding of the kinetics of peptide binding and cAMP signaling is
incomplete, and the molecular basis of long duration signaling is unclear. Our understanding of the interactions
of the receptors with the two other families of transducer proteins that mediate GPCR signaling, the GPCR
kinases (GRKs) and b-arrestins, is rudimentary. Moreover, there is still a need for better pharmacological tools
for studying the receptors. Accordingly, our goals are to further define the mechanisms by which RAMPs
determine CTR and CLR ligand selectivity, further characterize the kinetics of the molecular events leading to
cAMP signaling, and define the basis for long duration cAMP signaling. In addition, we will continue to engineer
novel peptide ligands and we will study the receptor interactions with GRK and b-arrestin transducers.

Public health relevance
NARRATIVE: This project uses powerful biochemistry, pharmacology, and structural biology techniques to reveal how CGRP family peptide hormones bind to their receptors on the surface of cells and transmit signals inside the cells. The hormones regulate bone remodeling, vascular tone, blood glucose, and food intake and the receptors are drug targets for diseases including osteoporosis, migraine headache, cardiovascular disorders, and diabetes and obesity. Our studies will facilitate the development of therapeutics targeting these receptors and reveal concepts that are broadly relevant for several areas of human health and disease because the receptors are members of the large GPCR family that regulates most aspects of human physiology.